Identifying human-specific neural progenitors and their role in neurodevelopment

PROJECT SUMMARY/ABSTRACT
Humans have highly advanced cognitive abilities and motor skills, characteristics which are reflected in the
enlarged size and cell diversity of our central nervous system (CNS). My overall goal is to profile and compare
progenitor cell diversity in humans, non-human primates and rodents, and thereby identify the origins of
increased cell diversity and size of the human CNS. As part of my postdoctoral research, I collected and analyzed
high-temporal-resolution single-cell RNA-seq data of the well characterized human and mouse spinal motor
neuron (MN) lineage, which led to the identification of a molecularly distinct, human-specific (i.e., not found in
mouse) motor neuron progenitor (hsPMN) cell type. I found that hsPMNs undergo delayed and protracted
neurogenesis, increasing total MN output by ~2-fold. The proposed study aims to characterize how they
contribute to the population size and subtype diversity of the MN lineage by combining single-cell RNA-seq with
long-term astrocyte co-culture or xeno-transplantation of lineage-labeled human cells. Second, the proposed
study will further investigate the evolution of hsPMN cells and their gene expression program by a) determining
whether an orthologous cell type is found in old-world monkeys (i.e., macaque), and b) identifying and functionally
testing newly evolved gene regulatory elements that give rise to hsPMN-specific gene expression patterns.
Finally, I will develop a 3D spinal organoid in vitro differentiation system that harbors spatially patterned ventral
and dorsal spinal lineages, using a standard set of differentiation conditions that can be applied to human,
macaque, and mouse cells. This last aim will broaden the scope of comparative investigations to encompass
multiple spinal lineages, thus opening up new avenues and hypotheses for future research, as well as providing
a more comprehensive in vitro model system of spinal cord development. The insights, protocols, and data
generated from this study will enable and provide valuable comparative analyses into human neural progenitor
diversity and how human-specific progenitors contribute to the size and cell diversity of the CNS during
development. Furthermore, these studies and data will form the foundation of my research agenda as an
independent investigator, while allow me to broaden my research training to include a diverse host of species,
model systems and a wide array of experimental as well as computational techniques.

Public health relevance
PROJECT NARRATIVE The human central nervous system (CNS) is characterized by an increase in cell diversity as well as size, features which underlie our amazing cognitive and behavioral capacity. Neural progenitor cells directly dictate both the size and cell diversity of the CNS; understanding how the human neural progenitor cell population differs from that of mice or monkeys is therefore fundamental to understanding what makes our nervous systems unique. This project will profile and compare neural progenitor cell diversity in humans, monkeys and mice, and thereby identify human- or primate-specific progenitor cells, as well as characterize how they contribute to CNS size and cell diversity.